Improving Prevention Systems to Reduce Disparities for High Priority Populations.

7. PROJECT SUMMARY
This project collaborates with the New York City Department of Health and Mental Hygiene (NYC DOHMH) to
develop and test a field-based comprehensive sexual health intervention for HIV-exposed contacts notified by
its Partner Services (i.e., HIV contact tracing) program. Individuals reached by PS programs are highest priority
for linkage to HIV prevention/care services: 10-20% are newly diagnosed with HIV as a result of PS notification
and the remainder are eligible and high priority for PrEP. Because they seek out highest-risk individuals in the
field, PS programs have the potential to significantly reduce existing disparities in PrEP uptake and timely HIV
care initiation by reaching populations that are currently under-engaged by traditional PrEP or HIV testing
programs. The new Partner Services-Sexual Health (PS-SH) intervention offers a comprehensive sexual
health package that includes HIV testing, STI testing, ARV/PrEP education and immediate medication start to
all individuals receiving contact notification (i.e., being notified of a recent exposure to HIV). NYCDOHMH is
collaborating on this research project to enable a scientifically rigorous test of the intervention’s efficacy and
produce the highest quality data on implementation dynamics, cost-effectiveness, and affordability to inform
dissemination and adaptation of the intervention, should it prove effective. The specific aims are to: (1) Pilot
and refine a field-based comprehensive sexual health intervention delivered through the NYC DOHMH Partner
Services Program. Under this aim, we will pilot the intervention in five highest prevalence NYC neighborhoods
for 6-months (n = ~60), examine feasibility and acceptability, and refine the intervention process and protocols
for the trial to test effectiveness at scale. (2) Examine the effectiveness of the Partner Services-Sexual Health
(PS-SH) intervention in improving rates of HIV testing, linkage to HIV prevention/care, and PrEP uptake among
highest risk contacts recently exposed to HIV. Under this aim, we will conduct a cross-sectional stepped wedge
cluster randomized trial in which 12 clusters of NYC neighborhoods are exposed to the intervention
sequentially, with three clusters moving from control to intervention every 6 months (n = 1150). Primary
outcomes are HIV testing, timely PrEP/ARV uptake, and linkage to PrEP/HIV care. Secondary outcomes are
STD testing and receipt of STD treatment (if indicated). (3) Conduct preliminary analyses of economic
outcomes, including cost-allocation and affordability to allow other jurisdictions to make decisions about
implementation. These analyses will include per-outcome cost-estimates, and will develop a blueprint for
economic evaluation of the intervention including incremental cost-effectiveness and budget impact analyses
for application locally and nationally. The proposed project is poised to have a significant and sustained impact
on the field by: a) addressing a critical gap in the prevention/care continuum to reduce persistent disparities in
the epidemic; and b) pioneering a collaborative implementation science approach to accelerate the
dissemination of evidence-based practice models across the United States and internationally.

Public health relevance
8. PROJECT NARRATIVE Severe disparities in PrEP access and uptake remain among populations most strongly impacted by the HIV epidemic. These same populations suffer from disproportionately high rates of undiagnosed infection and late treatment initiation that translate into high levels of HIV-related mobility and mortality. This implementation science project partners with a public health department to pioneer and rigorously test an innovative method for reaching highest risk populations and engaging them in HIV testing, PrEP, and/or ARV treatment to significantly positively impact the epidemic.